METAL IDENTIFICATION IN LUNG TISSUE IN AUTOPSY CASES FROM MEXICO CITY RESIDENTS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To analyze the metal components in lung samples of humans living in a high polluted city, with an increased death rates related with this issue.